Impact of Biological, Clinical, and Social Determinants on Trauma and Trauma Outcomes

PROJECT SUMMARY / ABSTRACT
This T32 grant, Impact of Biological, Clinical, and Social Determinants on Trauma and Trauma
Outcomes, will provide the training and mentoring to create the next generation of physician scientists.
Physician-scientists are a critical element of the workforce necessary to improve the health of patients.
Injuries and deaths from traumatic injury represent the major cause of death and impaired function among
people under the age of 44. This morbidity and mortality creates a disproportionate drain on healthcare
resources due to the typical young age of the trauma patient. Additionally, new advances in identifying the
scope of chronic traumatic encephalopathy (football players' brain injury) show the need for increased
investment in the basic science of trauma. Trauma also disproportionately affects underserved minority
patients, resulting in increased healthcare disparities in the United States. This highlights the need for
scientists who will lead studies to improve our understanding of and develop interventions to reduce
disparities in trauma care, risk of interpersonal violence (child abuse, intimate partner violence, elder
abuse) leading to trauma, and social determinants and trauma. This competing renewal will build on the
success of the prior ten years of funding. These successes include effective recruitment of minority
physicians into the program, 112 publications authored by 17 trainees, including 54 first-author
publications. Some of the significant changes in the new application include inclusion of health services
and population sciences faculty mentors to support and mentor trainees increasing interest in these areas
of research related to causes and outcomes of traumatic events. This grant specifically requests funding for
two postdoctoral fellows for two years of training, a formula which has proven successful since inception of
this training program. The Executive Committee works closely with the individual trainees to identify
mentors whose research matches the interests of the trainees. All of our prior trainees have been drawn
from the residency programs at Boston Medical Center, the largest safety net hospital in New England.
There is exceptional institutional commitment manifest by the support for the recruitment and retention of
minority physicians and trainees with disabilities. The productivity of trainees both during and after their
participation in this fellowship demonstrate that we have prepared our trainees for academic careers.

Public health relevance
PROJECT NARRATIVE Traumatic injury causes significant mortality and morbidity beyond just the physical damage from the initial traumatic event. This grant will train physicians to become investigators who study the basic biology of how trauma alters the immune system, clinical care of trauma patients, social determinants of trauma and trauma outcomes.